Chemical tools to decode nuclear lamina-ome

Project Summary
The goal of this application is to image and identify nuclear lamina-interacting proteins in living cells. The
nuclear lamina, located underneath of inner nuclear envelope, is composed of four major homologous
proteins, lamin A (LA), lamin B1 (LB1), lamin B2 (LB2) and lamin C (LC). Lamins are type V intermediate
filament proteins and provide mechanical support for the mammalian nucleus. However, the roles of lamins
have been significant extended into other critical aspects of cell biology including mechanosensing DNA
repair, chromatin regulation, gene transcription and stem cell regulation. The function of lamins in these
processes are mediated by complex yet incompletely understood protein-protein interactions at the nuclear
lamina. The importance of LA in these biological processes is further emphasized by the fact that more
than 450 LA mutations are known to cause a wide spectrum of diseases collectively called laminopathies.
One of the major obstacles in addressing this challenge is the lack of the appropriate tools and
technologies to image and identify the lamina-binding proteins in living cells under physiologically relevant
conditions. We recently developed a small molecule called LBL1 that specifically binds lamins in the whole
cellular proteome. Our identification of LBL1 provides an unprecedented opportunity for us to image and
identify the endogenous lamin-binding proteins in living cells. This understanding will generate novel
insights into the lamin functions and potentially provide novel avenues to develop therapies for
laminopathies. To achieve this goal, we propose the following two specific aims: 1) To develop an
innovative chemical probe to label nuclear lamina in living cells; 2) To identify and image LA and its
interacting partners in living cells.

Public health relevance
Project Narrative The proposed research is to develop a method to image and identify nuclear lamina-interacting proteins in living cells. This will help identify novel avenues to develop therapies for laminopathies.